P30 Administrative Supplement for Multi-Channel Communication Campaigns for Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations

PROJECT ABSTRACT
Childhood cancer survivors are a high-priority, underserved population for HPV vaccination. They are less
likely to be vaccinated when compared to the general population and are more likely to develop second
cancers caused by HPV as adults. St. Jude Comprehensive Cancer Center (SJCCC) is uniquely positioned to
address observed disparities in HPV vaccination coverage among childhood cancer survivors by leveraging
our unique reach across our catchment area and building on award-winning, state-of-the-art communication
systems with those treated at SJCCC and their families. The purpose of this proposal is, therefore, to further
develop, optimize, and evaluate the Survivor Proud campaign to promote HPV vaccination to childhood cancer
survivors (Track 1: 9-30 years). We will focus specifically on continuous quality improvement of the campaign
through ongoing evaluation activities and successfully sustaining elements of the campaign that are most
effective. We also will focus on important wrap-around activities in support of the communication campaign,
including peer-to-peer efforts for patient families and clinician education and training. We will leverage
established infrastructure and collaborations to achieve the following specific aims: 1) Optimize and expand the
innovative, culturally targeted, multi-channel Survivor Proud communication campaign to enhance health
literacy related to HPV vaccination and to improve HPV vaccination coverage among CCS; and 2) Evaluate the
impact of the campaign to understand its impact on awareness, knowledge, intentions to get HPV vaccination,
and actual HPV vaccination, when data are available. Our approach will be highly iterative and include
engagement of key offices within St. Jude and most importantly, through our continued regular interaction with
patient families and adult childhood cancer survivors. The Survivor Proud campaign focuses on web-based
resources and communities, social media platforms, mobile application (app), traditional print formats,
electronic medical record (EMR) prompted patient education prescriptions, direct e-communication, peer-to-
peer, patient family experiences, and clinician training and education. The Survivor Proud HPV vaccination
campaign has first been developed in English (and will be developed in Spanish) will be evaluated across
these communication channels. A focus of the campaign is to build confidence in HPV vaccination leveraging
the trusted relationship patient families have with St. Jude. Project activities are documented and monitored
through a comprehensive process evaluation. Preliminary impact of our efforts will also be measured using
qualitative, quantitative, and analytical data, including assessment of aggregated HPV vaccination rates before
and after campaign implementation. Our efforts will be aligned with existing St. Jude resources from the
beginning to optimize sustainability. We will openly share our findings with other cancer centers and
organizations serving CCS and continue to refine and test our approaches to ensure we are achieving impact
through increased HPV vaccination coverage among childhood cancer survivors.

Public health relevance
PROJECT NARRATIVE Childhood cancer survivors are a high-priority, underserved population for HPV vaccination because they are less likely to be vaccinated and more likely to develop second cancers caused by HPV as adults when compared to the general population. This project will use an iterative, participatory, and collaborative approach to leverage, build on, optimize, and expand an HPV vaccination campaign for childhood cancer survivors to include peer-to-peer patient family experienced and clinician education and training.